Analysis of galectin-8 and its ligands in melanoma progression

With successes in cancer treatment becoming more common, treating patients with metastatic melanoma
(MM) is still grim. The advent of immune checkpoint inhibition (ICI) therapy, particularly, has revolutionized the
promise of generating more durable responses; however, the 5-year survival rate for patients with MM remains
only ~23%. Due to therapy resistance and persistence of tumor-initiating cell (TIC) subpopulations, there is a
vital need for predictive biomarkers of therapeutic response and novel therapeutic targets to augment current
treatments for MM. Our laboratory has recently pioneered investigations on the signature features of the
human MM cell glycome and how these discrete glycans and glycan-binding factors impact melanoma
progression. The MM glycome is characterized by an abundance of cell surface i-linear poly-N-
acetyllactosamines (linear poly-LacNAc) via loss of I-branching poly-LacNAc enzyme GCNT2 and elevations in
LacNAc-binding lectin, galectin (Gal)-8. In fact, low melanoma cell GCNT2/I-branching corresponds with
human MM progression, whereas detection of Gal-8 in serum directly correlates with a diagnosis of melanoma.
Exciting, published data show that elevations in MM cell Gal-8 and Gal-8-binding linear poly-LacNAcs directly
result in expression a key TIC factor, nerve growth factor receptor (NGFR)/CD271, a known driver of therapy
resistance and MM progression. Engagement of this Gal-8 – Gal-8 ligand axis enhances TIC potential, pAKT
activity, and in vivo tumor-forming activity of human MM cells. Our guiding hypothesis is that the MM
glycome helps govern the malignant traits and capacity for melanomas to metastasize. Expression of
Gal-8 and its glycoprotein ligands bearing linear poly-LacNAcs may help predict which melanomas will
metastasize and even provide new opportunities to treat patients with MM. In this grant, we will conduct
molecular characterization of the MM cell Gal-8 – ligand axis, probe the role of Gal-8 in melanoma growth and
metastasis, and determine whether melanoma-intrinsic or host Gal-8 impacts melanoma immunity and alters
anti-tumor responses to ICI therapy. The Specific Aims are: 1.) To examine the functional role of the Gal-8
– ligand axis in melanoma progression, and 2.) To analyze the growth- and metastasis-promoting roles
of Gal-8 in melanoma. We are implementing: 1.) a strong investigator team consisting of glyco-analytics
experts, clinical investigators, melanoma pathologists, and galectin biology experts; 2.) primary human
melanoma tissues and stage-specific melanoma patient serum samples; 3.) innovative Gal-8 ligand/glycan
assessment methods; and 4.) pre-clinical mouse and MM cell Gal-8-deficient models to impart the most
impactful comprehensive data in this project. Results from this transformative proposal will illuminate how MM
glycome regulates MM TIC factor, NGFR, and melanoma growth and metastasis, implicating Gal-8 and linear
poly-LacNAcs as biomarkers or therapeutic targets of MM progression.

Public health relevance
The overall objective of the grant is to understand how the melanoma glycome, which is the repertoire of cellular glycans and glycan-binding proteins, impacts metastatic progression. Our proposed studies seek to investigate whether a newly-described glycome pathway in metastatic melanoma cells is critical for melanoma metastasis and a potential target for effective anti-metastatic therapy. These findings will help illuminate the value of novel human melanoma glycome features as clinical biomarkers for diagnosing melanoma development or for prognosticating clinical outcome and treatment strategies.